The recruitment and retention of colon intraepithelial lymphocytes

Project Summary
An intact epithelial barrier is key for maintaining intestinal homeostasis and preventing inflammation. Barrier
dysfunction has been associated with inflammatory bowel disease and increased susceptibility to enteric
infection. Previous work from the Kuhn lab has demonstrated that IL-6 produced by TCRαβ+ CD4+ colon
intraepithelial lymphocytes (cIELs) are required to maintain epithelial barrier integrity and thus intestinal
homeostasis. In contrast with phenotypically distinct small intestine IELs, which have been widely characterized,
very little is known about cIEL function and development beyond the importance of IL-6 production. This project
aims to define the mechanism that recruits cIELs to and retains them in the epithelium. Preliminary data indicate
that upon exposure to luminal bacteria, myeloid cells produce sphingosine-1-phosphate (S1P) in a MyD88-
dependent fashion. Conditional knockout of MyD88 in myeloid cells and S1P signaling blockade significantly
reduce the number of TCRαβ+ CD4+ cIELs in the epithelium. However, further experiments are required to
confirm this mechanism and understand the characteristics of recruited cIELs. Intestinal epithelial cells (IECs)
express MHC class II (MHCII) and act as non-professional antigen presenting cells capable of influencing T cell
function independent of local dendritic cells, and conditional knockout of MHCII on IECs changes cIEL effector-
memory ratios. This proposal hypothesizes that intestinal bacteria are recognized by myeloid cells to recruit
commensal reactive cIELs through S1P signaling to the epithelium, where interactions with epithelial MHCII lead
to tolerance. Aim 1 seeks to demonstrate the mechanism by which myeloid cells recruit commensal reactive
cIELs to the colon epithelium. The requirement for cIEL S1P signaling and myeloid cells will be shown by
inhibiting each variable using the S1P receptor 1 inhibitor W146 and CD11c-DTR mice, respectively. cIELs will
be stained for markers of differentiation, antigen experience, and activation. Commensal-reactive cIELs will also
be identified by staining with MHCII-restricted tetramers containing the commensal antigenic peptide Cbir1, and
their TCR Vβ chains will be identified using a flow screening panel. Aim 2 will investigate the mechanism by
which cIELs are recruited to the colon epithelium by utilizing a conditional knockout mouse line in which IECs
are deficient in MHCII (MHCIIΔIEC). Single cell assay for transposase-accessible chromatin (ATAC) sequencing
and bulk T cell receptor (TCR) sequencing will be performed on cIELs from MHCIIΔIEC and MHCIIWT mice. These
experiments will identify how epithelial MHCII influences cIEL gene regulation and TCR repertoire diversity,
respectively. Lastly, MHCIIΔIEC and MHCIIWT mice will be infected with the murine enteric pathogen Citrobacter
rodentium. This experiment will demonstrate the importance of epithelial MHCII in influencing cIELs in the
immune response.

Public health relevance
Project Narrative Maintenance of a healthy epithelial barrier is essential for intestinal homeostasis, and both genetic deficiencies in barrier function and evidence of functional barrier dysregulation are observed in patients with inflammatory bowel disease. Previous work has shown that colon intraepithelial lymphocytes are required to maintain and repair the epithelial barrier, but their function is largely unstudied. This project aims to understand the role of epithelial antigen presentation in informing tolerance and function of colon intraepithelial lymphocytes, which will increase understanding of the etiology of diseases such as inflammatory bowel disease.